Discovery of Chemical Probes and Therapeutic Leads, Phase 3

Project Summary
The goal of this Phase III COBRE to continue and sustain our work to discover new chemical probes and lead
molecules for biological research and therapeutic discovery. Our approach is broad-based and interdisciplinary,
with a focus on using chemical biology and molecular design to investigate and understand disease while
leveraging our core capabilities in synthesis, biochemistry, engineering, and biology. Building on the successes
of Phase I and II, our center will continue to build center momentum with the continued recruitment and
development of new investigators through faculty hiring and through pilot project funding. During Phase III, we
will continue to support our successful and broadly utilized cores, and we outline a plan for sustaining the cores
beyond COBRE funding with a broad base of extramurally funded user groups and an outstanding University
commitment to support the cores through a significant match commitment and hard-funded Ph.D. level staff. We
will sponsor an annual seminar series to be hosted by COBRE investigators and the UD Allies for a Culture of
Inclusive Diversity (ACID) committee. The center will develop resources for mentoring and professional
development including Grant Development Awards, UD ACID activities, MIRA workshops, NIH Diversity
Supplement workshops, and Career Long Collaborative workshops. Center progress will be evaluated by an
Advisory Committee that will meet twice per year. Our Center will collaborate with other centers in the Delaware
IDeA network, UD centers and the NIH funded Chemical-Biology Interface (CBI) Training grant centered at UD
in order to maximize our research capacity. Discovery COBRE values the importance of diverse teams working
together to maximize innovation. In Phase III, our center will create infrastructure for biomedical research teams
who bring diverse backgrounds and expertise to our center.

Public health relevance
Project Narrative This Center of Biomedical Research Excellence is a multidisciplinary center that is using synthesis, chemical biology and computation to develop molecular approaches for understanding and treating human disease, with a focus on infectious diseases and cancer.